Administration Core

PROJECT SUMMARY/ABSTRACT – ADMINISTRATIVE CORE
The overall goal of the Administrative Core, led by PI Dr Kirsi Järvinen-Seppo, is to provide the organizational
backbone and leadership for this Program entitled “Biomarkers of Atopy Beginning Early” (BABE). The
Administrative Core will provide overall and fiscal management, communication, coordination, and supervision
of the program Projects and Cores and will coordinate interaction with other AADCRC Research Programs,
AADCRC Steering Committee (and subcommittees), and NIAID. This includes managerial support, annual
progress reports, and fiscal management, implementing and monitoring a project management plan, defining
timelines, and overseeing adherence to compliance to data sharing. This will ensure that investigator efforts
are coordinated, progress is regularly evaluated, the resources are optimized and scientific plans are revised
based on feedback.